DRP: Developmental Research Program

The Developmental Research Program (DRP) of the Hillman Cancer Center (HCC) Ovarian SPORE seeks to fund and facilitate translationally-driven, innovative pilot projects in ovarian cancer. The overarching goal is to decrease ovarian cancer morbidity and mortality through stimulating new research in the areas of prevention and early detection; mechanisms of tumorigenesis and therapeutic resistance; predictive and prognostic biomarkers; and novel targets and approaches to therapy. To accomplish these goals, DRP will build on the successful program and infrastructure developed via a previous joint P50 award that resulted in an approximate 35-fold return on investment. The DRP will widely solicit proposals annually using local and national networks. The most meritorious proposals will be selected based on an NIH-style two-tiered review to ensure rigor and absence of bias. The DRP Co-Directors, SPORE Executive Committee, Patient Advocates, and SPORE investigators will participate in the first-tier scientific review, together with ad hoc reviewers when necessary. The final selection of awardees will be made following a second-tier programmatic review involving the SPORE Internal Advisory Board. Each award will provide $50,000 in funds, with half of the monies coming from the DRP and the other half from HCC, demonstrating substantial institutional commitment. DRP will fund two pilots per year. DRP awardees new to ovarian cancer will be assigned an experienced mentor to provide guidance and integration into the SPORE. Awardees will be provided full access to the HCC Ovarian Cancer SPORE Core resources, including tissue specimens and bioinformatic/biostatistical support, not only to ensure project success but also to support subsequent funding applications outside the SPORE mechanism. All DRP awardees will meet bi-annually with the DRP Co-Directors, prepare progress reports annually, and make research presentations at SPORE meetings. Those that demonstrate significant research progress will be eligible for competitive renewal for a second year. Exceptional pilots with potential for significant translational impact can be elevated to full SPORE projects. The DRP provides a vital mechanism for achieving the SPORE’s goal of developing a strong pool of ovarian cancer projects aimed at overcoming this deadly disease.

Public health relevance
The Developmental Research Program (DRP) of the UPMC Hillman Cancer Center (HCC) Ovarian Cancer SPORE seeks to identify, fund and facilitate translationally-driven, innovative pilot projects in cancer through broad solicitation of proposals, vigorous peer-review, and assessment of pilot progress with intent to develop mature projects worthy of extramural support (including SPORE rebid efforts). Submissions from investigators new to this field, and high-risk, high-gain proposals will be strongly encouraged and all awardees will have the full support of SPORE and HCC resources to increase likelihood for success.